FLUCONAZOLE IN SUPPRESSION OF RELAPSE OF HISTOPLASMOSIS IN AIDS

This study evaluates the use of fluconazole as initial treatment and maintenance therapy to patient relapse in AIDS patients with histoplasmosis.